WASHINGTON UNIVERSITY SCIENCE PARTNERSHIP PROGRAM - BUILDING STEM CAREER READINESS IN K-12 STUDENTS

ABSTRACT
To maintain its status as the worldwide leader in research, the United States must realize the tremendous
scientific power inherent within its diverse population. Currently, much of this potential, however, remains latent,
as Black, Hispanic, and Native American students are underrepresented in college STEM majors, STEM PhD
programs, the professoriate, and the STEM workforce. The creation of holistic K-12 programs that spark student
interest in science, empower their academic pursuits, and provide them with bona fide research experiences is
essential to enhance the migration of talented, STEM-focused, minoritized students into college STEM majors.
Such efforts are critical for the U.S. to realize the immense latent scientific potential contained within its diverse
population. By leveraging established partnerships with community K-12 organizations, and listening to the
needs of our partners and their students, we have sculpted a new, integrated program that will provide holistic
training and support to minoritized, low-income high school students to help them succeed in STEM. A key
feature of our program is that we will leverage the interest and intellect of undergraduate, post-bac, and PhD
students in the diversity-focused programs we run to ensure that high school students are mentored by STEM
role models who look like them.
Aim 1: To create educational programs that address partner-identified STEM education gaps and to determine
if student participation in these programs increases science literacy, scholastic success, college matriculation,
and motivation to pursue scientific careers relative to non-participating students. We hypothesize these activities
will have strong, positive impact on students because we are addressing specific needs defined by their
educational organizations. Aim 2: To determine whether the context in which research experiences are delivered
impacts motivation to enter STEM fields. We hypothesize that, in our student population, research experiences
focused on health disparities that disproportionately affect Black people will be more motivating for long-term
scientific engagement compared with similar research projects that lack this societal context.
We partner with Jennings High School, The Sophia Project, and The Village. The demographics of our partners
resemble those of the Jennings School District, where over 98% of the students are Black, all qualify for the Free
Federal Lunch program, and 38% of school age children live in poverty. At Jennings, high school graduation
rates exceed 90%, but less than half of these students enter a two- or four-year college. Most students lack
academic/STEM role models as well as opportunities to learn about and pursue an interest in STEM. Our
program then possesses immense potential to positively impact the confidence and college and career choice
of these students and thus help diversify the next generation of scientists.

Public health relevance
NARRATIVE The creation of holistic K-12 programs that spark student interest in science, empower their academic pursuits, and provide them with bona fide research experiences is essential to enhance the migration of talented, STEM-focused, minoritized students into college STEM majors. Such efforts are essential for the U.S. to realize the immense latent scientific potential contained within its diverse population. By leveraging partnerships with community K-12 organizations and listening to the needs of our partners and their students, we have sculpted a new, integrated program that will provide holistic training and support to minoritized, low- income high school students to help them succeed in STEM.